Reconstruction of three-dimensional organ of Corti micromechanical motion patterns via optical coherence tomography

Optical coherence tomography (OCT) is used in cochlear mechanics research to image and measure
vibrations in the organ of Corti complex (OCC), the sensory tissue that spirals within the cochlea. OCT can
be used to measure sub-nanometer vibrations at many points along the optical axis simultaneously.
However, this optical axis does not generally bear a straightforward relation to the anatomy of the
cochlea. This results in two ambiguities: 1) the measured motion is a projection of the true three-
dimensional motion onto an axis that is not anatomically important, and 2) the relative locations of
measured structures are known only along the optical axis, which is not sufficient to relate the structures
anatomically. This results in limitations for the interpretation of OCT data, as measurements taken at two
different orientations cannot be reasonably compared to one another. Even simultaneously measured
structures in a single measurement cannot be adequately compared, as their relative locations are not
necessarily known. The purpose of this project is to overcome these limitations of contemporary OCT
experiments and gain a full three-dimensional picture of micromechanics in the base of the gerbil cochlea.
These quantitative three-dimensional measurements will reveal mechanical properties governing
cochlear tuning and transduction, such as the OCC effective mass and stereocilia pivoting. In Aim 1, we
propose the use of densely spaced OCT measurements in a volume of the gerbil cochlea base at three
different orientations to reconstruct the three-dimensional OCC motion. In Aim 2, we propose the use of
compressed sensing to reduce the number of spatial samples required for this reconstruction, and
consequently reduce the acquisition time of this three-dimensional vibration data. Aim 2 is based in the
expectation - which will be tested in this project - that the motion pattern of the OCC can be expressed
sparsely in some set of basis functions, for example, a wavelet basis. Finding such a basis would give
significant insight into the spatial structure of in vivo cochlear micromechanics. The method will be made
available through a public GitHub repository.

Public health relevance
The goal of this project is to measure the three-dimensional motion pattern of the organ of Corti complex in gerbil in vivo. This would give the most complete picture of in vivo cochlear micromechanics in a mammal to date, providing fundamental knowledge about the operation of the hearing organ.